Selective Editing of the Mutant Huntingtin Gene

The cause of Huntington’s disease is an increase in the trinucleotide CAG repeat from under 36
repeats to 36 or greater repeats. The mode for the number of repeats is 42, and most patients have between
40 and 45. The disease generally starts between ages 30 and 40, with onset and progression of impaired
cognition, depression, and aberrant movement. The genetics is autosomal dominant. With gene editing, we
aim to eliminate expression of the mutant allele of Huntington’s disease or repair the mutation by reducing the
number of CAG repeats. We will use CRISPR-Cas9 for selective targeting of single nucleotide polymorphisms
with heterozygosities to prevent the mutant huntingtin allele from producing protein. Generating frameshift
mutations at the SNP heterozygosity reduces mutant huntingtin protein, with no production of mutant protein
fragments. In a second approach, we reduce the number of CAG repeats from a high number in the mutant
allele to a healthy number of CAG repeats, through the use of Cas9 nickases. The nickase Cas9D10A is used to
reduce the CAG repeat number below the pathogenic threshold. We have preliminary data that supports each
aspect of the proposal. The goal of this discovery application is to set the stage for promising therapeutics for
treatment of Huntington’s disease and other autosomal dominant neurological disorders caused by
trinucleotide CAG repeat expansions.

Public health relevance
Huntingtin’s disease (HD) is based on a mutation in a gene called huntingtin. Huntington’s disease is inherited as autosomal dominant, which means that an affected parent would have a 50:50 chance of passing the gene to a child. All who inherit the mutation will eventually develop the disease, with impaired cognition (dementia), depression and apathy, and abnormal movements. Patients will need to receive long-term skilled nursing for many years. We use gene editing to either eliminate the mutant gene that causes the disease or correct the mutation itself. Our discoveries will set the stage for a new paradigm of therapeutics for an array of neurological diseases, including those with increased numbers of repeats of sequences in genes, such as HD, other CAG repeat expansions, and brain diseases with dementia and movement problems (C9ORF based amyotrophic lateral sclerosis and frontal-temporal dementia). Our program has public health relevance. Diseases marked by dementia and severe movement limitations are expensive to society, by requiring high level nursing care. Patients are removed from the active work force, thus lowering their earning capacity. These diseases reduce the gross national product. The stress on public health for HD in particular is that the disease affects individuals in the prime of their lives – magnifying the economic burden while intensifying family hardship. Reversing HD or delaying its onset will have economic as well as health benefits.